Identifying Immune and Epithelial Network Signatures in Very Early Onset Inflammatory Bowel Disease

Project Summary
Our goal is to build a comprehensive atlas of intestinal epithelial, stromal, and immune cells from both monogenic
and polygenic very early onset inflammatory bowel disease (VEOIBD) patients (0<6 years of age) at the single
cell level by leveraging the diverse expertise of our VEOIBD Consortium (www.veoibd.org). We hypothesize that
developing this atlas will inform upon disease pathogenesis and enable targeted therapeutics for VEOIBD.
Moreover, identification and characterization of novel VEOIBD causative genetic variants will inform upon novel
IBD pathogenic networks extending beyond VEOIBD. We selected key members of our Consortium to facilitate
these goals, including three core patient recruitment sites (Dr. Scott Snapper, Boston; Dr. Christoph Klein,
Munich; Dr. Aleixo Muise Toronto), each with combined expertise in immune phenotyping (Snapper),
transcriptomics (Dr. Snapper, Dr. Alex Shalek, Dr. Ordovas-Montanes, Kean), proteomics (Dr. Mathias Mann),
functional genomics (Drs. Muise, Dr. Klein, Dr. Snapper) as well as expertise in intestinal organoid generation
and functional assessments (Dr. Hans Clevers/Dr. Edward Nieuwenhuis), data analysis/network development
(Dr. Eric Schadt) and data sharing (Dr. Larsson Omberg/Sage Bionetwoks). To generate a VEOIBD cellular and
molecular atlas, our goal is to pursue in VEOIBD patients a multi-omic approach to generate in-depth patient-
specific libraries of data including: 1) single cell and bulk transcriptomic and proteomic data generation from
biopsies; 2) paired single cell and bulk transcriptomics and proteomics from patient-derived organoids; 3) paired
transcriptomics, and proteomics from patient blood. To further inform upon this data set, we will couple these
data with deep immune phenotyping (through mass cytometry) and functional characterization of VEOIBD
patient-derived organoids. In this application, we propose to study 150-200 VEOIBD patients (< 6 years) and 30-
40 age-matched controls employing bulk and single-cell RNA sequencing and proteomics from biopsies and
paired peripheral blood samples. In addition, we will perform deep immune phenotyping on intestinal biopsies
(75-100 patients; 15-20 controls) with paired peripheral blood, as well as organoid development coupled with
bulk and single cell RNA sequencing and functional assessments on 100-150 VEOIBD patients and 20-30
controls. The multitude of cell types in the intestine contributing to disease pathology has to date been mostly
studied in aggregate form. In order to deconvolute the cell specific signal within the tissue and ‘assign’ disease
relevance, we will apply our multiscale network (MultiNet) approaches in combination with single cell omics
technology. Based on the above data sets, we will validate novel VEOIBD causal gene variants which will not
only lead to a better understanding of the disease for these patients but also enhance the development of the
VEOIBD immune atlas and epithelial signature and associated networks. Importantly, we will share these
libraries of data and organoids with the scientific community to accelerate our mission of identifying therapeutic
targets, and cures for VEOIBD.

Public health relevance
Project Narrative In this ambitious team science grant, we propose to develop the first single cell very early onset inflammatory bowel diseases (VEOIBD) cellular atlas and associated VEOIBD networks. We hypothesize that developing this atlas will inform upon disease pathogenesis and enable targeted therapeutics for VEOIBD patients. Moreover, identification and characterization of novel VEOIBD causative genetic variants will inform upon novel IBD pathogenic networks extending beyond VEOIBD. Robust data and resource (organoid) sharing will facilitate translational research and the identification of therapeutic targets for common forms of IBD.